Administrative Core

PROJECT SUMMARY - ADMINISTRATIVE CORE
The ultimate goal of an Alzheimer's Disease Research Center (ADRC) is to promote innovative research on
dementia and its treatments while ensuring that patients and caregivers become the beneficiaries of resultant
advances. An effective Administrative Core is essential for transforming these goals into accomplishments. To
this end, the Administrative Core of the Northwestern ADRC will be guided by the following goals:
1) Lead the day-to-day running of the ADRC and promote "centerness" so that ADRC components function
cohesively and leverage dementia-related activities throughout Northwestern University.
2) Maximize the utilization of ADRC resources to fit local and national priorities.
3) Coordinate the adoption of UDS-3, the FTLD module, new clinical trials, and the increased emphasis on
biomarkers, including structural and molecular imaging.
4) Facilitate interactions with NACC, NCRAD, and national consortia such as ADNI and ADCS, the
Alzheimer's Association, and relevant agencies within the City of Chicago and State of Illinois.
5) Encourage innovative Development Projects, coordinate their review, and monitor the progress of those
that receive ADRC funding.
To fulfill these goals, the Administrative Core will oversee the finances of the parent NIA P30 and of additional
contracts related to multi-center collaborations and clinical trials. It will be responsible for timely progress
reports related to these activities as well as the organization of the yearly Scientific Advisory Board (SAB)
meeting. An equally important role will be to ensure that the ADRC as a whole meets all IRB and HIPAA
requirements and that it is in compliance with NIH policies for human subjects, animal welfare, scientific
integrity, data and sample sharing and financial policy. The Administrative Core is also responsible for
coordinating the interactions of the ADRC with NIA, other NIH components, other ADRCs, and relevant
agencies at the national, state and local levels. Within Northwestern University, the Administrative Core will
advocate the allocation of additional faculty, space and financial resources to dementia research.